Chaperone-Mediated Protein Degradation of Bcl-xL and Bcl-2

Project Summary
Targeting the anti-apoptotic Bcl-2 family proteins is a promising therapeutic strategy for cancer and has been
validated by the FDA approval of the Bcl-2 selective inhibitor, venetoclax, for the treatment of chronic lymphocytic
leukemia (CLL) and acute myeloid leukemia (AML). Given the well-documented importance of Bcl-xL to many
types of cancers, including most T-cell acute lymphoblastic leukemia (T-ALL), and its contribution to drug
resistance, Bcl-xL has become one of the best validated cancer targets. Unfortunately, the on-target and dose-
limiting platelet toxicity associated with the inhibition of Bcl-xL has prevented the use of Bcl-xL inhibitors in the
clinic. To circumvent this toxicity, we have applied the Proteolysis Targeting Chimera (PROTAC) technology to
design small-molecules that target Bcl-xL to E3 ligases for degradation. Our hypothesis is that Bcl-xL degrading
PROTACs (named as Bcl-Ps) designed to recruit an E3 ligase that is minimally expressed in platelets for the
targeted degradation of Bcl-xL will have reduced platelet toxicity and improved antitumor activity compared with
their corresponding Bcl-xL inhibitors. This hypothesis is supported by our strong preliminary results, including in
vivo efficacy data in T-ALL patient-derived xenograft (PDX) mouse models and other tumor xenograft mouse
models. In addition, our Bcl-Ps are also potent senolytic agents that can selectively kill senescent cells (SnCs),
because SnCs also rely on Bcl-xL for survival. Clearance of chemotherapy-induced SnCs is considered as a
novel strategy to prevent or reduce many short- and long-term adverse effects of the chemotherapeutic drugs,
as well as cancer relapse and metastasis. Collectively, these findings suggest that Bcl-Ps are superior to
conventional Bcl-xL inhibitors as anticancer agents. The goal of this application is to: (1) optimize Bcl-Ps for
improved potency, selectivity, drug-like properties, and in vivo efficacy; (2) evaluate the new Bcl-Ps through a
series of in vitro and in vivo assays; and (3) evaluate the preclinical efficacy of lead Bcl-Ps in T-ALL PDX models.
Upon completion of this project, we aim to produce Bcl-Ps amenable to further evaluation in clinical trials for T-
ALL, an aggressive leukemia that currently has no targeted therapies.

Public health relevance
PROJECT NARRATIVE The proposed research employs an emerging drug discovery technology, PROTAC, coupled with an innovative concept of E3 ligase based tissue specific induction of target protein degradation, to overcome the dose-limiting thrombocytopenia associated with inhibition of Bcl-xL in platelets. This could lead to a breakthrough in developing cancer therapies targeting Bcl-xL protein.